Developing and validating natural language processing tools for memory assessment

Alzheimer's disease is a debilitating condition that affects millions of people worldwide. Understanding the
progression of memory decline in Alzheimer's and other memory-related disorders is critical for developing
effective treatments and interventions. However, large-scale longitudinal studies of autobiographical memory,
which would provide insight into the progression of memory decline, have been difficult to conduct due to the
time and effort required to manually score the Autobiographical Interview, the gold-standard method for
assessing autobiographical memory. To reduce the scoring burden and enable larger studies on
autobiographical memory, PI Dr. van Genugten and OSC Dr. Schacter developed software to automatically
score interview responses with natural language processing. Preliminary validation of this AI tool with five
datasets shows strong agreement between software-generated and manually generated memory scores. This
grant proposes to further develop and rigorously evaluate this AI tool for automated memory scoring. In Aim 1,
we will use advanced machine learning methods to improve automated scoring accuracy. Specifically, we will
fine-tune state-of-the-art large language models using over 200,000 annotated memory details from existing
datasets to enhance performance. To address model limitations, we will use active learning to identify the
types of content that the model misclassifies, then augment the training data with additional annotated
examples of those types to improve accuracy. In Aim 2, we will develop software for more granular memory
scoring. This software will score memories for nine categories of episodic and non-episodic information,
including spatial and perceptual details. In Aim 3, we will conduct extensive psychometric analyses to evaluate
the validity and reliability of this software, leveraging an existing psychometrics dataset that includes more than
1,300 memories. Finally, we will evaluate automated scoring accuracy on data from across the lifespan and in
individuals with dementia, including individuals with Alzheimer's Disease, Semantic Dementia, and Fronto-
Temporal Dementia, using eleven existing datasets. Overall, the purpose of this grant is to develop and
rigorously evaluate software for automated memory scoring, enabling large-scale studies of autobiographical
memory and advancing the ability to study the progression of memory decline in Alzheimer's and other
memory-related disorders.

Public health relevance
Memory decline is a hallmark of Alzheimer's disease and related dementias. Large-scale studies of autobiographical memory are needed to better understand and eventually develop interventions for memory decline, yet current assessment methods make large studies impractical. We aim to overcome this challenge by developing software to automate memory assessment, enabling large-scale longitudinal studies that could improve our understanding of Alzheimer's and related diseases.